EFFECT OF ANTECEDENT HYPOGLYCEMIA ON HYPOGLYCEMIA UNAWARENESS

To determin the threshold for antecedent hypoglycemia to reduce symptoms and counterregulatory hormone responses to subsequent hypoglycemia and the time required for recovery as a function of the magnitude of the antecedent hypoglycemia. This currently a data analysis only protocol through CDMAS.